Pseudocannabinoids for mitigation of substance use disorder

Project Summary
Cannabidiol (CBD), the major component of Cannabis sativa, is best known for its anticonvulsant properties. It shows far
more potent antiseizure activity and weaker narcotic action than its minor counterpart, ∆9-tetrahydrocannabinol (THC).
Epidiolex, a herbal CBD preparation, was approved by the FDA in 2018 for the treatment of refractory seizures. However,
CBD is a low potency drug, requiring up to 25 mg/kg dosing. In addition to this, chemical conversion of CBD to THC is
trivial, requiring nothing more than a simple acid catalyst, and diversion of CBD to pure THC has the potential to spawn a
culture similar to that of the "meth lab" phenomenon. Thus, with the goal to produce less controversial, non-controlled,
abuse-proof and more potent drugs, Syncanica is developing fully synthetic analogs of 8,9-dihydrocannabidiol (H2CBD)
as therapeutic agents. The startup was launched with a first-case use to provide a better drug for epilepsy. That venture is
progressing, and the goal now is to broaden the range of indications. A new, high-potential therapeutic target is substance
use disorder (SUD), a devastating public health crisis for which current treatments show limited effectiveness.
Cannabis in general, and CBD specifically, has been widely investigated for its promise to manage addiction. Multiple
literature sources indicate that CBD can induce analgesia and also attenuate opioid-induced reward while reducing
withdrawal symptoms among individuals with opioid dependence. Interestingly, the opposite is true for THC, which
enhances opioid reward self-administration, as well as inducing acute cognitive and motor impairment. Syncanica's task is
now to develop and market a drug better than CBD in all respects. Already, literature evidence and our own work show
that analoging can lead to significant changes in potency and action. Preliminary behavior studies also indicate that
H2CBD has no sedative properties, unlike CBD, which is known to induce somnolence. Encouraged by these results and
ample literature evidence pointing to CBD's potential in SUD therapy, we now propose to validate the pharmacological
and pharmacokinetic properties of H2CBD and its analogs via the following Aims:
Aim 1: Synthesize a series of H2CBD analogs. Efficient, scalable, synthetic routes to H2CBD and a set of 15 analogs
will be employed to enable the follow-up pharmacological and pharmacokinetic studies in Aims 2 and 3.
Aim 2: Evaluate H2CBD analogs in a zebrafish model of addiction and pain. The candidate compounds from Aim 1
will undergo preliminary testing in a larval zebrafish assay to confirm the absence of unwanted side effects including
sedation and motor impairment. We will then utilize the zebrafish's robust nociceptive response to the photochemical
irritant optovin to assess how H2CBD analogs attenuate pain related behaviors. Finally, efficacy in reducing drug-seeking
behaviors will be quantified using an established adult zebrafish opioid self-administration assay.
Aim 3: Conduct pharmacokinetic (PK) studies of H2CBD analogs in rodents. The PK parameters (exposure,
distribution, and half-life) will be determined to ultimately determine dose ranges for a rodent study in Phase II and for the
identification of the degradation pathways of H2CBD analogs by examining their metabolites, ultimately clearing the path
for an IND application.

Public health relevance
Project Narrative Overdoses involving opioids take the lives of more than 80,000 people annually in the US (2021 statistic), making the development of new analgesics and addiction therapeutics an urgent medical imperative. We propose here to develop analogs of H2CBD, a synthetic pseudocannabinoid with no narcotic abuse liability, as safe, legal, and effective drugs to combat opioid use disorder (OUD). The successful advancement of this class of therapeutics would benefit an increasing population of opioid users whose quality of life is severely compromised by OUD.